Neurodevelopment of exploration and alcohol problems in adolescence

PROJECT SUMMARY
Exploring novel and unfamiliar foods, friend groups, and activities during adolescence critically shapes our
preferences and personalities in adulthood. Conversely, for adolescents who engage in underage drinking,
such novelty-seeking can be maladaptive and lead to the development of chronic alcohol use problems. Cross-
sectional studies suggest that individuals become more strategic in their use of goal-directed exploration to
optimize choice during the transition from adolescence to young adulthood. The core hypothesis of the
proposed study is that the maturation of directed exploration is blunted or lagged in adolescents who
experiment with alcohol and go on to develop increased alcohol use problems. Specifically, we will conduct an
accelerated longitudinal fMRI study of N=135 participants (recruited at 13-21 years), merging clinical assays of
alcohol use severity, computational modeling of novelty-driven exploration across multiple tasks, model-based
decomposition of fMRI data at three longitudinal timepoints, and smartphone-based daily diary assessments to
probe alcohol- and novelty-related decision making in vivo outside of the laboratory. In Aim 1 we will test the
hypothesis that the normative maturation of novelty-driven exploration—i.e., expansion of strategic, goal-
directed exploration to optimize choice—will be negatively modulated by increased alcohol use severity.
Further, we will use longitudinal model-based fMRI to determine whether this expansion of directed exploration
is driven by age-related increases in neural encoding of the latent value of exploring new options in
frontoparietal (i.e., frontopolar cortex, dorsolateral prefrontal cortex, and intraparietal lobule) and motivational
(i.e., striatum, amygdala, and orbitofrontal cortex) neural circuits. In Aim 2 we will contrast novelty-driven
exploration to maximize gains versus minimize losses, hypothesizing that the presence of potential
punishments should decrease exploratory behavior as individuals are motivated to avoid potential losses.
Differentiation between reward- and punishment-evoked neural responses is blunted in adolescents with
alcohol use problems, therefore we hypothesize that differential gating of novelty exploration across gain
versus loss contexts will be diminished in adolescents with higher alcohol use severity. Lastly, in Aim 3 we will
use daily diary prompts delivered via smartphone to determine the ecological relevance of our laboratory-
based decision making assays for predicting real-world alcohol- and novelty-directed behaviors. This
triangulation of computational phenotyping, neuroimaging, and ecologically-situated assessments has not been
performed in existing studies, and could identify a new novelty-driven exploration dimension to be considered
in future iterations of the Addictions Neuroclinical Assessment framework. In line with the Katz Early Stage
Investigator mechanism—this computational developmental science approach will represent an innovative
advance that will launch the PI in a new research direction: leveraging his skills and expertise in adolescent
neuroimaging to focus on the development of decision making neurocircuitry and risk for alcohol use problems
in adolescence.

Public health relevance
PROJECT NARRATIVE The proposed longitudinal study examines the maturation of brain and behavioral mechanisms that motivate the exploration of novel choice options in adolescents and young adults with varying degrees of alcohol use problems. We will test the overarching hypothesis that persistent immaturity of exploratory decision making computations predicts greater alcohol use problems in adolescence and young adulthood. This study uses an innovative computational developmental neuroscience approach to chart the growth curves of different novelty- directed behaviors in adolescence and young adulthood, which could aid in the design of preventative interventions for reducing alcohol use disorder risk in adolescence.